Stress-Induced Aging: Investigating Chronic Wound Stress as a Catalyst for Systemic Aging and Functional Decline

Stress-Induced Aging: Investigating Chronic Wound Stress as a Catalyst for Systemic Aging and
Functional Decline
Chronic wounds, defined by delayed healing and frequent recurrence, often manifest in adulthood due to
complex factors that disrupt normal repair and impose sustained physiological stress on the body. These wounds
share biological features associated with aging, such as cellular senescence, chronic inflammation, epigenetic
alterations, stem cell depletion, and extracellular matrix dysfunction. However, it remains unclear whether the
local repeated stress of chronic wounds contributes to systemic aging, although individuals with chronic wounds
often exhibit aging-associated characteristics like frailty, muscle weakness, reduced mobility, and impaired
immunity. In this project, we hypothesize that prolonged exposure to recurrent wound stress in adulthood
accelerates both molecular and functional aging. The study will be conducted in two phases. In the R61 phase,
we will establish a mouse model simulating chronic wound stress across different adult life stages and assess
the impact on aging hallmarks and functional decline. This model will allow us to investigate and measure
biological aging changes, such as senescence and inflammation, and physical outcomes, including frailty and
sarcopenia. The R33 phase will examine how pre-existing frailty exacerbates aging in the context of chronic
wounds, using hind-limb suspension to mimic physical frailty. Additionally, we will test interventions—senolytics,
anti-inflammatory agents, and exercise—to mitigate molecular and functional aging. This research aims to
establish chronic wound stress as a driver of aging and identify therapeutic targets to improve resilience and
functional outcomes in adults burdened by chronic wounds.

Public health relevance
Chronic wounds, characterized by delayed healing and high recurrence, emerge in adulthood due to a complex interplay of intrinsic and extrinsic factors that disrupt normal repair processes, trigger systemic physiological changes, and impose repeated stress. This project aims to investigate how the stress of chronic wounds, compounded by factors such as frailty, accelerates biological aging and functional decline. Utilizing a novel mouse model of prolonged wounding across different life stages, we will assess the impact of these stressors on aging hallmarks and test targeted interventions—including senolytics, anti-inflammatory agents, and exercise—to improve healing outcomes and mitigate the effects of aging in this vulnerable population.